Consequences of nicotine exposure on dopamine D2 binding in Adolescence and adulthood. An in-vivo positron emission tomography (PET) study in rats.

PROJECT SUMMARY Nicotine use is typically initiated in adolescence—more than 90% of smokers begin smoking before the age of 18—yet not enough is known regarding how nicotine may affect adolescent brain development into adulthood. During adolescence, the dopaminergic system and dopamine D2 receptor (D2R) levels in particular are in flux. The effects of nicotine exposure during this developmentally crucial time may lead to changes in D2R levels that persist into adulthood. Since an individual's D2R levels are thought to affect cognition, mood, and addictive as well as other problem behaviors, it is of the utmost importance to investigate whether nicotine exposure in adolescence can enact long-lasting alterations to D2R binding in the adult brain. Ethical limitations mandate that this question cannot be directly studied in adolescent humans, and thus information can only be derived from animal models. This project combines µPET imaging with a rat model of adolescent nicotine use, allowing for the in-vivo characterization of the effects of early nicotine exposure on adult dopamine receptor levels. This research has three specific aims, to: 1. Characterize in-vivo baseline D2R binding in the adolescent brain (P30) compared to the adult brain (P60). 2. Determine the effect of chronic adolescent (P30) nicotine exposure on D2R binding in-vivo in adult rats (P60). 3. Determine the effect of adult-onset (P60) chronic nicotine exposure on D2R binding in-vivo in adult rats (P90). PET imaging will be performed using [11C]raclopride to measure D2R binding. We will first image rats at baseline in early adolescence or early adulthood. We will then treat each age group with twice daily doses of nicotine for two weeks, followed by a 16-day period of cessation. On the last day of cessation, we will conduct the post-treatment scan. We will follow the same rats longitudinally (imaging adolescents first at age 30 days and a second time at age 60 days, adults at age 60 days then again at age 90 days), to obtain a within-subject characterization of the long-term changes to D2R binding that occur in response to treatment. This experiment will provide us with in-vivo insight into how nicotine administration at different ages affects the dopaminergic system. By focusing on molecular consequences of nicotine exposure in adolescence, this work provides an opportunity to inform future prevention measures and potential medication treatments for addiction, as well as a greater understanding of adolescent brain development.

Public health relevance
PROJECT NARRATIVE Of the more than one billion people who use tobacco worldwide, the overwhelming majority begin during adolescence, a time where the brain is exquisitely sensitive to the effects of drug exposure. Using PET imaging in rats, this project aims to investigate in-vivo whether exposure to nicotine during adolescence alters the normal trajectory of dopaminergic development to result in lasting alterations in baseline dopamine D2 receptor levels in adulthood–which has the potential to affect mood, response to reward, and cognition. Despite the historical decline in tobacco use in our country, E-cigarettes and related products have caused a resurgence in nicotine use among youth, and so it is imperative that we obtain a better understanding of nicotine's effects on the developing brain, so as to inform future novel interventions, preventive measures, and successful public health policies.